Subwavelength ultrasound focusing using negative index refraction metamaterials

SUMMARY/ABSTRACT
Ultrasound is one of the most versatile tools in medicine for non-invasive imaging and therapies.
As with any wave phenomenon, one of the limitations in ultrasound resolution is the diffraction
limit. In this project, we propose the use of negative-index non-resonant acoustic metamaterials
(NRAM) for ultrasound focusing exploiting their negative-index refraction and sub-wavelength
focusing. Negative acoustic metamaterials have shown exciting properties such as amplification
of evanescent waves,1–3 negative phase velocities (phase propagates in opposite direction to
group propagation),4–7 impedance matching to enhance ultrasound transmission,7 and negative
refraction angles.8,9 Using these properties, NRAM have demonstrated experimentally novel
capabilities such as ultrasound sub-wavelength imaging, and imaging and focusing with
rectangular slabs that produce mirroring images of ultrasound point sources.1–3 Many of these
properties could bring major benefits for biomedical ultrasound.6,7,10,11 However, such capabilities
have been shown only at low frequencies in the 1-60 kHz range,3,7,9 impeding their study and
application at biomedical ultrasound frequencies. The low-frequency operation of metamaterials
has been due mainly to technology limitations. However, recently our research group
demonstrated a novel metamaterial technology achieving a 1-D negative-index behavior at 300
kHz in water incorporating <100 micrometer membranes and Helmholtz resonators,12 placing us
in an ideal position to study the potential impact of NRAM for biomedical ultrasound. For this
exploratory R21 project, we aim to build 2-D and 3-D negative electroactive metamaterials
operating at 2 MHz to demonstrate negative refractive index and dynamic sub-wavelength
focusing. Specifically, we aim to 1) demonstrate negative index and negative-angle refraction to
achieve ultrasound focusing at 2 MHz frequency using negative metamaterial slabs, 2)
demonstrate sub-wavelength focusing targeting 0.250.1 mm lateral focusing at 2 MHz, and 3)
demonstrate electroactive dynamic focusing and acoustic index tuning at 2 MHz using
piezoelectric-based NRAM. This exploratory project aims to demonstrate the technological
capability of negative-index acoustic metamaterials to facilitate ultrasound focusing and improve
resolution. The success of this exploratory project will provide experimental evidence to expand
this effort and aim for higher frequency operation towards 5 MHz and to develop electro-active
tunable metamaterials that can lead to active and adjustable focusing for ultrasound applications
such as transcranial ultrasound imaging, therapies and stimulation.

Public health relevance
PROJECT NARRATIVE This proposal aims to use electroactive tunable broadband negative-index acoustic metamaterials to achieve negative refraction angle and dynamically controlled subwavelength focusing at relevant biomedical ultrasound frequencies in water. Advances in active micro-electro-mechanical systems now allow the fabrication micro-acoustic components <100 m that can operate above 1 MHz in liquid, opening a technological route to manipulate ultrasound at the sub-wavelength regime. In this project, we aim to show proof-of-concept of tunable negative-angle refraction and sub-wavelength dynamic focusing with acoustic metamaterials to improve ultrasound resolution.